Adapting Survivorship Care to Rural Practice, Translating Rural Evidence into Policy

Abstract
In response to the widening rural-urban cancer mortality gap in the US, our parent research project aimed to
improve access to comprehensive cancer care in rural communities by extending the resources and expertise of
a large academic medical center out to a network of rural community cancer centers to improve the quality and
comprehensiveness of care across the cancer continuum, from diagnosis and treatment to survivorship
services. This initiative holds particular significance for Iowa, which, like other rural states, has witnessed a
surge in cancer incidence coupled with rising prevalence of cancer survivors. The primary aim of the parent
grant was to effectively implement an adapted affiliate cancer network model to meet the unique needs of rural
Iowa cancer centers. Building on our progress, this current supplement leverages the mentoring skills of our
Principal Investigator (PI) to promote the sustainability of our network intervention and develop the next
generation of rural cancer researchers. Having already identified the importance of adapting evidence-based
interventions to meet the needs of rural cancer center administrators and providers, our first supplemental
objective is to host a novel cancer survivorship workshop designed specifically for rural providers,
administrators, and policymakers. Under the mentorship of our PI, two early-stage investigators in the fields of
implementation science and disparities research will lead efforts to adapt and implement a rural cancer
survivorship workshop from a model created at the University of Iowa Holden Comprehensive Cancer Center.
This rural cancer survivorship workshop is poised to bolster the capacity of stakeholders within the Iowa
Cancer Affiliate Network (I-CAN) to deliver cancer survivorship services in their rural communities. The
second mentoring aim of this supplemental proposal aims to continue efforts ensuring that rural cancer
survivorship research translates to effective rural policy and practice. To promote effective engagement with
policymakers, the PI will mentor an early-stage rural cancer research trainee and equip him with the skills to
communicate and network with a broader public policymaking audience. The mentee will be integrated into
the PI’s extensive network of academic, healthcare, and policymaking leaders in Iowa, facilitating the creation
and distribution of rural cancer equity products to key decision-making stakeholders. At the end of the
supplemental grant, the mentee will disseminate reports to policy makers in each of Iowa’s 99 counties (78
being rural). By detailing the cancer burden of their specific county, policymakers will be better equipped to
prioritize cancer prevention and control strategies. The parent research project represents a collaborative
effort, featuring a diverse research team committed to addressing the challenges facing rural patients and
cancer centers. This proposal supplements our novel intervention to promote its sustainability and cultivate the
next generation of rural cancer leaders, advancing the NIH’s mission to create a more diverse workforce.

Public health relevance
NARRATIVE Developing engagement and policy translation skills of the next generation of rural cancer researchers will prove critical as many rural states experience rising cancer incidence amidst growing prevalence of cancer survivors. Greater access to comprehensive survivorship services could mitigate the growing mortality disparity between rural-urban cancer patients, but rural cancer centers need additional support to deliver such care locally. Leveraging the resources of an innovative cancer center network intervention, we propose to implement an evidence-based survivorship workshop adapted to fit the unique needs of rural communities and explore innovative approaches to disseminate our cancer equity research to rural policymakers.